PHASE II RADOMIZED OPEN LABEL TRIAL OF ATOVAQUONE PLUS PYRIMETHAMINE

A Phase II Randomized Open-label Trial of Atovaquone Plus Pyrimethamine and Atovaquone Plus Sulfadiazine for the Treatment of Acute Toxoplasmic Encephalitis.